Enhancing radioligand therapy for prostate cancer with biomarker and dosimetry guided personalization

ABSTRACT
Radiopharmaceutical therapy (RPT) that delivers targeted cytotoxic radiation to cancer cells is typically
administered on a fixed activity basis, without personalization, in stark contrast to external beam radiotherapy.
177Lu-labelled prostate-specific membrane antigen (PSMA) targeted radioligand therapy (RLT) is a promising
RPT for metastatic castrate resistant prostate cancer (mCRPC) that was recently FDA approved as a fixed
activity treatment (7.4 GBq/cycle delivered over 6 cycles). This standardized approach fails to take advantage of
unique properties inherent to 177Lu: in addition to therapeutic beta particles, 177Lu emits gamma-rays imageable
by SPECT, allowing precise absorbed dose (AD) estimation to plan subsequent cycle/s. Additionally, pre-therapy
PSMA-PET imaging can potentially be used to predict ADs before initiating RLT. Furthermore, preliminary data
demonstrate an important finding: AD deposition per injected activity (Gy/GBq) is substantially higher in the first
cycle for tumor, while it remains relatively constant across cycles for organs, motivating consideration of
administering higher activity in the first cycle. While standard 177Lu-PSMA RLT has demonstrated a favorable
toxicity profile, the AD to critical organs such as bone marrow (BM) needs to be considered when escalating
dosage. However, BM dosimetry in mCRPC is complex because tumor infiltration of spongiosa is common.
Although the current approach to RLT has led to promising early response rates in mCRPC, the complete
response rate and overall survival remain poor; this raises the question of whether dosage escalation with
patient-specific dosimetry may be key to more optimal outcomes, and provides the rationale for our study. Our
long-term goal is to achieve durable responses with RLT in mCRPC. To advance this goal, the objectives of the
current application are to develop the tools and predictive models that will provide the capacity for dosimetry-
guided treatment, and to evaluate the feasibility of dosage escalation. For the proposed developments, except
the clinical trial, imaging data from 50 patients who are undergoing standard RLT will be used. 1) In Aim 1, a
novel method for BM dosimetry will be developed by coupling macro/micro Monte Carlo modeling with images
of lesion and marrow distribution in spongiosa, 2) in Aim 2 models will be built to predict AD from pre-therapy
quantitative 68Ga-PSMA PET, tumor AD vs. response, and normal organ/BM AD vs. toxicity using biomarkers as
covariates and 3) in Aim 3, tracer kinetic modeling will be performed with dynamic PET to determine optimal
timing of escalated dosage delivery to avoid PSMA-receptor saturation that may impede benefits of escalation.
This will be followed by a Phase I clinical trial for cycle 1 dosage escalation in 20 patients with low risk for
hematotoxicity with the primary endpoint of safety; this will identify the recommended dosage for a future Phase
II/III trial powered to evaluate efficacy. This work will have a significant impact because it will enable novel, more
patient-centered delivery of RLT, which currently lacks dosimetry-based optimization. The concepts/tools that
are developed will be applicable to all forms of RPT, a rapidly growing treatment option for various cancers.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on developing an alternative strategy for radiopharmaceutical therapy that enables optimized, personalized dosing based on absorbed dose predictions. Such an approach is expected to result in durable responses in cancer patients that are typically not achieved with the fixed activity treatment commonly used in radiopharmaceutical therapy today.